Safety and Tolerability of Ultra-short Course Rifapentine and Isoniazid (1HP) for Prevention of Tuberculosis in HIV-Uninfected Individuals

Project Summary
Tuberculosis (TB) is the leading infectious cause of death due to a single pathogen globally and the UN has
set ambitious targets for reducing the burden of TB by 2030. TB preventive therapy (TPT) is a critical
intervention for preventing TB disease and modeling studies consistently indicate that expanded TPT coverage
is essential for reaching UN targets. Implementation of TPT among the populations at risk remains extremely
poor, however, and new regimens that are shorter and safer than the decades-old standard of isoniazid
preventive therapy are urgently needed. Over the past several decades, we have pioneered the development
of short-course, rifamycin-based TPT. We demonstrated the efficacy of 3 months of weekly rifapentine and
isoniazid (3HP) in people with and without HIV infection and showed that it is non-inferior to longer courses of
isoniazid, with better adherence and less toxicity. This regimen is now recommended as a first-line treatment
for latent TB infection by the CDC and the World Health Organization, offering the potential of substantially
increased uptake of TPT as part of the END TB Strategy. More recently, supported by NIAID, we have shown
that one month of daily rifapentine and isoniazid (1HP) is non-inferior to nine months of isoniazid in people with
HIV infection, with higher completion rates and less toxicity. The availability of two innovative, new short-
course TPT regimens offers a transformative opportunity to global TB control. The potential of a one-month
regimen to catalyze uptake of TPT in high-risk populations is enormous, but data on its safety and tolerability in
people without HIV infection are needed.
The goal of this investigator-initiated, clinical trial application is to conduct a randomized trial comparing
treatment success rates and safety of 1HP and 3HP TPT regimens in high-risk patients without HIV infection.
While 3HP has been proved safe and effective in HIV-positive and –negative people, 1HP has only been
shown to be safe and efficacious in HIV-positive people. Efficacy of 1HP in non-HIV populations may be
inferred based on previous experience that shows comparability of TPT regimens across risk groups, but
toxicity and tolerability is not known. We will 1) compare treatment success with good adherence, documented
by self-report, pill count, and pharmacologic monitoring, of 1HP compared with 3HP in HIV-uninfected adults
and adolescents at increased risk of TB and 2) compare the safety of 1HP vs 3HP in this population. We
hypothesize that successful treatment with 1HP will be superior to 3HP, and that the safety and tolerability of
1HP will be superior to 3HP. We will also compare the cost-effectiveness of 1HP and 3HP using a societal
approach, modeling the incremental cost-effectiveness of 1HP vs 3HP, 6H, and no treatment. We hypothesize
that 1HP will be cost saving vs 3HP, vs modelled costs of 6H and v no TPT. The results of this trial will be
extremely valuable for establishing global and US guidelines for use of 1HP in HIV-negative people.

Public health relevance
PROJECT NARRATIVE Tuberculosis is a leading infectious killer worldwide. TB preventive therapy (TPT) is highly efficacious but poorly implemented. New shorter regimens that have better adherence and safety are now available and can contribute to epidemic control. We plan to conduct a randomized trial of one-month of daily rifapentine and isoniazid compared with three months of the same drugs given weekly in people without HIV infection to determine adherence to and safety of these regimens. We will also assess the cost-effectiveness of these two regimens.